Longitudinal multimodal mapping to decipher the neurovascular impact of microinfarcts

PROJECT SUMMARY:
Cerebral microinfarcts are in association with neurologic dysfunctions in aged and injured brain where they are
found to be prevalent, but often escape clinical detection owing to their small sizes. Although evidence
suggests that microinfarcts likely have a distinct time course and spatial pattern compared to larger infarcts,
spatially-resolved, longitudinal tracking of both hemodynamic and neural responses in the same brain has not
been realized, largely due to a lack of methods capable of quantifying multiple neurophysiological and
hemodynamic parameters with sufficient spatial resolution over periods of weeks to months. As a result, the
neurophysiological consequences of individual or cumulative microinfarcts, including their spatiotemporal
evolution and long-term outcome, remain largely unknown, limiting our ability to identify and target them for
intervention strategies. The long-term goal is to understand the pathological impacts of microinfarcts with
variability in abundance, spatial distribution, occurrence time and risk factors similar to human patients. The
objective of this project is to determine the neural and hemodynamic impact of individual and cumulative
cerebral microinfarcts in a mouse model. The hypothesis is that microinfarcts lead to spatiotemporally varying
neuronal impairment and hemodynamic deficits that extend well beyond the lesion site and into chronic time
scales, which requires spatially resolving and longitudinal tracking of multiple neurophysiological parameters
over weeks to months to reveal their full impacts. We will use two types of ultra-flexible neural electrode arrays
for spatially-resolved surface and intracortical recording, both of which are compatible with chronic optical
methods. We will combine neural recording with a set of optical systems that are able to induce targeted micro-
occlusions with controlled size, location and onset time, and to map and quantify cerebral blood flow and
oxygenation over a global field of view and at depth-resolved microscopic scales. Using awake, behaving
animals, we will 1) determine the correlation between hemodynamic and neural changes induced by individual
microinfarcts, 2) map and track the spatial extent of microinfarcts at controlled lesion sizes, and 3) determine
the hemodynamic and neural impacts of cumulative microinfarcts with delayed onset time. The application is
highly innovative, in the applicant’s opinion, because it integrates technical advancements on both functional
imaging and neural recording to provide a highly novel and powerful combination that permits longitudinal,
spatially resolved quantification of multiple neurophysiological parameters in the same brain region and allows
for investigation of microinfarcts in previously unattainable regimes. The project will improve the understanding
of the physiological impact of microinfarcts and their contribution to neurologic dysfunctions in a variety of
neurodegenerative and cerebrovascular diseases that they coexist with, and provide new insight into the
therapeutic time window for intervention.

Public health relevance
PROJECT NARRATIVE: Microinfarcts are in association with a number of cerebrovascular diseases but their hemodynamic and neurological consequences are insufficiently understood. This project uses cutting-edge imaging and recording techniques to reveal the neurovascular impacts of individual and cumulative microinfarcts including their time course and spatial extent, so that they can be identified and targeted in the correct time window for effective intervention.